Expanding the impact of cancer prevention policies through collaborative implementation research: a qualitative secondary analysis of federal child nutrition assistance policies during COVID-19

ABSTRACT
Evidence-informed public health policies have tremendous potential to reduce cancer health inequities by
addressing cancer risk factors among priority populations. This impact is only achievable if policies are well-
implemented among populations at greatest risk. Understanding how policy implementation varies across
contexts is critical to developing tailored, equity-focused implementation strategies, but opportunities to
evaluate these variations are sparse. This study evaluates variations in implementation of federal policies
aimed at reducing child food insecurity and improving dietary intake during the COVID-19 crisis, in order to
inform future implementation and sustainment strategies. Child nutrition programs (CNPs) are federally-funded,
evidence-based programs to mitigate child food insecurity, a social determinant of health that is associated
with many cancer risk factors (e.g., poor diet, asthma, obesity, chronic disease), and is disproportionately
prevalent among Black and Hispanic/Latino children and those in low-income households. CNPs are offered
year-round and reduce food insecurity and improve diet quality among enrolled children, yet reach and
implementation of CNPs varies, especially in summer. CNP mandates are quite rigid, which limits adoption and
in some districts (e.g., highly urban/rural or under-resourced), and stifles efforts to improve implementation and
expand student reach. In the extraordinary circumstance of the COVID-19 crisis, however, the US Department
of Agriculture allowed more flexibility so that CNPs could use novel implementation strategies to keep serving
meals while reducing virus spread (e.g., home delivery via bus routes, waived adoption requirements).
Understanding adoption and implementation of these strategies—especially variations across under-resourced
districts—is critical to advocate for more equitable policies, and inform tailored implementation support (e.g.,
technical assistance from state entities) for CNPs following the crisis. This study leverages a national research
collaborative to conduct a secondary analysis of implementation data from six studies during the initial COVID-
19 response (~Spring-Summer 2020) among CNP implementers (e.g., food service directors), combined with
data verification with CNP implementers and families post-initial response (~Fall 2022). Driven by the Dynamic
Sustainability Framework and CDC’s Policy Analytical Framework, we aim to: (1) describe system- and setting-
level variations in CNP policy implementation during COVID-19, including challenges and facilitators, key
partners, capacity, and adaptations; and (2) describe potential for sustainment of policy flexibilities,
implementation support needs, and critical policy levers to continue novel implementation strategies beyond
the COVID-19 crisis period. Findings can inform more equitable policies and tailored practice guidance, and
generate data for a hybrid implementation trial to compare the reach, effectiveness, and sustainment potential
of novel CNP implementation strategies to reduce food insecurity and promote health equity.

Public health relevance
PROJECT NARRATIVE Child food insecurity, a social determinant of health associated with myriad cancer risk factors, was exacerbated during the COVID-19 crisis, particularly among Black and Hispanic/Latino children and children living in low-income households. During the crisis, federal policies allowed child nutrition assistance programs (CNPs), which effectively mitigate food insecurity through provision of continuous, nutritious meals, to expand operations by using innovative implementation strategies to serve meals while reducing virus spread. This study seeks to describe variations in implementation of these policies across the country and understand the extent to which innovative strategies could be sustained in districts serving children most likely to experience food insecurity beyond the COVID-19 crisis, in order to address inequities and reduce risk for cancer and other chronic diseases.